CENTRAL NEURAL CONTROL OF SYMPATHETIC NERVE RESPONSES TO STRESS

Systematic evaluation of the central nervous system mechanisms which regulate central sympathetic neural outflow during acute stress in normotensives and borderline hypertensives.